Coregistered Photoacoustic and Ultrasound Imaging for Ovarian Cancer Diagnosis and Risk Management

Co-registered photoacoustic and ultrasound imaging for non-invasive ovarian cancer diagnosis
and risk management
Abstract
Worldwide, the estimated annual incidence of ovarian cancer is 204,000, with 125,000 deaths. Despite
advances in therapy, ovarian cancer remains the most deadly of the gynecological cancers. Less than
30% of women with advanced stage disease survive long-term. One of the reasons for the high fatality
rate is that more than 70% of women with ovarian cancer are diagnosed with advanced disease.
Photoacoustic tomography is an emerging technology that maps tumor vasculature content and oxygen
saturation, which are functional biomarkers of malignant development. Using co-registered
photoacoustic tomography (PAT) and ultrasound (US), we have developed a new noninvasive
transvaginal imaging device for non-invasive diagnosis of ovarian cancer. Initial data have shown that
co-registered PAT/US identifies invasive epithelial ovarian cancers by demonstrating extensively
distributed and higher levels of relative total hemoglobin (rHbT) in the US-identified region of interest
(ROI), as compared with more scattered and lower levels of relative total hemoglobin in benign and
normal ovaries (p=0.01). PAT/US identifies invasive epithelial ovarian cancers, as well as non-invasive
borderline and stromal tumors, by differentiating the lower SO2 in the US-identified ROI from the higher
values in benign and normal ovaries (p=0.003).
In this proposed work, we will 1) optimize our co-registered photoacoustic and ultrasound system and
user interface, 2) develop and validate classification models using photoacoustic functional imaging
biomarkers, PAT/US spectral features, and the known biomarker CA125, and 3) develop light fluence
correction algorithms for quantitative photoacoustic imaging to characterize ovarian tissue vasculature.
We will prospectively assess the ability of co-registered PAT/US to assist conventional imaging for
more accurate diagnosis of ovarian cancers and reduction of benign surgeries, without compromising
cancer detection. We will also monitor a group of high-risk women to determine if co-registered
PAT/US can be used as a potential sensitive and specific screening tool to differentiate normal from
early angiogenesis changes of the malignant process. The successful completion of the project will
provide a means to improve the current clinical practice.

Public health relevance
Project Narrative: We have developed a new transvaginal imaging device that uses a co-registered photoacoustic and ultrasound technique for more accurate ovarian cancer diagnosis. In this project, the new imaging device will be optimized and prospectively evaluated by a team of radiologists to determine if the device can improve the current clinical practice by more accurately diagnosing ovarian cancers and reducing unnecessary benign surgeries. The new imaging device will also be used to screen a small group of women who have increased risk of ovarian cancer to determine its effectiveness on early ovarian cancer detection.